Cell Subtype Mechanisms Underlying Stress Susceptibility and Resilience

Summary/Abstract
Repeated stress alters the structure and function of brain reward circuitry leading to disruption of the
motivated pursuit of rewards. Stress can be a major risk factor or trigger episodes of psychiatric disorders, which
are hallmarked by altered motivational processing observed in major depressive disorder, bipolar disorder,
schizophrenia, and post-traumatic stress disorder. The nucleus is a critical brain hub for altered cellular and
molecular actions underlying motivated behaviors in rodents and many of these adaptations are observed in
postmortem NAc of individuals with mental illness, such as depression. Previously we uncovered dendritic
atrophy, which correlated with disrupted activity and excitatory function, in NAc dopamine receptor 1 expressing
medium spiny neurons (D1-MSNs), of mice displaying reduced social interaction and anhedonia after chronic
social defeat stress (CSDS). While our group has delineated intrinsic mechanism that drive these morphological
adaptations, the extrinsic factors are unknown. Mounting evidence implicates microglia, which play a role in
shaping neuron dendritic adaptations, in social defeat stress outcomes. Thus, the parent grant investigates
microglia mechanisms that may regulate D1-MSN dendritic atrophy in social stress models in both sexes.
However, the proposed studies in the parent grant do not address the temporal dynamics that microglia
initiate mechanisms to drive the D1-MSN atrophy during stress. Data we are generating from the parent grant
suggest that microglia around D1-MSNs, in stressed animals, are phagocytic. However, these data also implicate
reduced D1-MSN-microglia contact and reduced microglia density surrounding D1-MSNs suggesting that
microglia have already impacted D1-MSNs at this time point where atrophy is observed. Based on this data, we
hypothesize that microglia display a temporal increase in contact with NAc D1-MSNs and activation of phagocytic
markers throughout social stress exposure, which will be assessed in this diversity supplement. In this proposal
a set of experimental Aims and a training plan are devised to provide technical training in neuron-microglia
morphological analysis and gene expression of microglia across a temporal profile of stress exposure. The
technical training is accompanied by conceptual training in microglia biology, reward circuit biology, and
molecular neuroscience. Additional, training and career development are outlined in the proposal to foster the
candidate’s growth toward applying for a F99/K00 and completing the milestones of the PhD thesis.